Los Angeles Area Health Services Research Training Program

Project Summary/Abstract
The Department of Health Policy and Management at the UCLA Fielding School of Public Health, in
collaboration with RAND Health, the Schaeffer Center for Health Economics at the University of Southern
California, and the Veterans Administration Center for the Study of Healthcare Innovation, Implementation and
Policy, proposes the renewal of its pre- and postdoctoral training grant, which has had an outstanding record of
producing the next generation of scholars over the past 25 years. The goal of the Los Angeles Area Health
Services Research Training Program is to provide comprehensive training and experience to highly-qualified
pre- and postdoctoral trainees, so that they may effectively engage in, and ultimately lead, research and
implementation activities aimed at improving the quality and efficiency of the U.S. health care system, and be
able to effectively inform both public and private policymakers how to design and assess such activities and
changes.
Taking advantage of the expertise of faculty and researchers at these institutions – over three dozen of whom
have agreed to be mentors – as well as a track-record of community involvement in the Los Angeles area, the
Training Program focuses on several key research topics in which the collaboration has particular expertise:
insurance, payment, and health system change; implementation, improvement science, and learning health
systems; patient, provider, and organizational decision-making; health outcomes measurement; health equity;
community-oriented population health; and health services outside of the clinic.
Predoctoral trainees will complete the Ph.D. curriculum and requirements in the UCLA Department of Health
Policy and Management. The Ph.D. program is designed to provide high-level methodological skills and
applied training, with depth in study design and evaluation, statistics/econometrics, and applications to the
health care sector. Moreover, each student is required to choose a cognate (examples include economics,
sociology, public policy, organizational behavior, and health care outcomes research) in which they take
additional courses that develop competencies in cognate-related theory, conceptual models and research
methods.
The postdoctoral program will provide individualized training plans for postdoctoral trainees. Unlike many such
programs in the sciences, trainees are not assigned to work on particular projects. Upon entry into the
program, they meet individually with key faculty involved in the Training Program at the four collaborating
institutions so that they can learn about the opportunities in each institution and choose appropriate mentors
and projects. During their postdoctoral experience, they collaborate with the program's faculty and
researchers, develop their own research, submit journal articles, and write grant proposals to help facilitate
their move to their next professional position.

Public health relevance
Project Narrative There is a shortage of highly trained professionals in the field of health services research, and, historically many of those trained have not benefited from a truly multidisciplinary perspective. The Research Program forges an alliance between the UCLA Fielding School of Public Health, David Geffen School of Medicine at UCLA, RAND Health, and relevant divisions at the University of Southern California and the Veterans Administration, to help train the workforce needed to tackle these key societal problems.